Biomedical Data Sets and Services Core

Summary
The Biomedical Data Sets and Services Core (BDSSC) of this COBRE will be established to expand
services and expertise provided beyond federal datasets to encompass all types of data utilized by the
Research Project Leaders (RPLs) who will be supported by this Phase 1 COBRE and future iterations. The
BDSSC’s primary innovation will be linking biomedical, environmental, and health records data to survey data
that collects demographic, marital status, family structure, education, and employment data to understand how
behavior, environment and biology combine to influence health outcomes. The BDSSC will achieve these
goals with the specific aims of: 1) assisting RPLs with data discovery and procurement for project
development; 2) building analysis datasets and providing statistical analysis for project execution; and 3)
expand core productivity to support COBRE stakeholders including RPLs, mentors, new faculty and other
biomedical and social science researchers. Building on the success of the BDSSC, researchers at KU and
across our region will have access to a new resource to support additional biomedical research funding in the
ever-advancing field of complex data science. As of now, no data services center exists at KU or in the region.
The BDSSC will create research capacity not currently available on campus to support data-intensive research
across the biomedical, behavioral, health, and social sciences to support fundamental research designed to
improve health outcomes.